Mechanisms of gene regulation by long noncoding RNAs

ABSTRACT
Only about 1% of the mammalian genome encodes for protein yet 80% is transcribed, suggesting that noncoding
RNA has many roles in gene regulation. Our research program aims to delineate those roles and the
mechanisms involved. Over the next five years, our focus will be the study of long noncoding RNAs (lncRNAs)
that function to repress transcription. The most potent repressive lncRNA, Xist, silences transcription across one
entire X chromosome during the essential process of X-inactivation. Yet the mechanisms by which Xist and other
lncRNAs repress transcription are insufficiently understood. Indeed, at the level of RNA sequence, it is unclear
what distinguishes repressive lncRNAs from those that lack repressive activity. This same lack of clarity extends
to lncRNAs of all functional classes. Thus, it remains nearly impossible to predict the function of lncRNAs from
analyses of their sequence content, stifling progress in the field. At the same time, lncRNAs play critical roles in
health. Abnormal expression of genes that lncRNAs target for repression can drive genetic disorders such as
Angelman and Rett Syndromes, as well as cancers and autoimmunity. Moreover, uncharacterized lncRNAs are
found throughout mammalian genomes, including in regions linked to phenotypic variation and disease, hinting
that lncRNAs with therapeutic relevance remain to be discovered. Additionally, we have discovered that many
intron-containing RNAs closely resemble known repressive lncRNAs. Although introns are better known for their
roles as substrates in the context of splicing, our data raise the intriguing possibility that intronic portions of the
nascent transcriptome mediate lncRNA-like regulatory effects. Over the next five years, our research program
will reveal fundamental insights into lncRNA biology and transcriptional control that are relevant across cell types
and organisms. We expect to determine how RNA sequence and structure confer repressive function to
lncRNAs; define new connections between nascent RNAs, RNA processing, and epigenetic regulation; delineate
new mechanisms through which RNAs use RNA-binding proteins to control transcription; and identify how the
regulatory functions of lncRNAs are modulated by underlying features of the genome. Along the way, we will
develop experimental and computational approaches that will enable regulatory RNAs and their mechanisms to
be identified across biological systems. Given the centrality of gene regulation in human health and disease, we
expect our work to lead to the discovery of etiologies and therapeutic opportunities in many settings.

Public health relevance
NARRATIVE Long noncoding RNAs (lncRNAs) play critical roles in health and homeostasis by regulating gene expression, but their mechanisms of action are poorly defined. Our research will determine how lncRNAs and proteins interact to achieve specific gene regulatory outcomes and will develop new ways to predict the presence of regulatory function in lncRNAs. We expect our work to reveal new and conserved mechanisms of gene regulation as well as disease etiologies and therapeutic opportunities in many settings.